Reframing Optimal Management of Pain and Opioids in Older Adults

Project Summary.
The prevalence of self-reported pain among older adults has increased 2-3 percent annually
in recent decades. Safely prescribing opioids or alternatives for geriatric pain requires
consideration of polypharmacy, cognitive and physical function, caregivers, social supportive
services, and end-of-life preferences. Practice improvement efforts have rarely been directed
at primary care (PC) practices with a large proportion of geriatric patients, so most older
adults do not receive a proper risk assessment, including for opioid use disorder (OUD). The
proposed project, Managing Pain Safely in Older Adults, is a partnership between the
University of Michigan (UM) and Altarum, bringing extensive expertise in implementing pain
management practice improvements through multi-faceted approaches using evidence-
based prescriber education, academic detailing, ongoing feedback, practice management
and prescriber support, as well as leveraging electronic health record (EHR) technology. The
UM and Altarum are in the third year of a partnership leading a Health and Human Services,
Office of Minority Health-funded program to prevent and reduce opioid-related morbidity and
mortality (Detroit Opioid Prevention Collaborative), using intervention strategies like those we
propose for this project. Our Managing Pain Safely in Older Adults project combines
Altarum’s expertise in engaging hundreds of PC practices in quality improvement and
provider and patient education programs, along with their nationally recognized expertise in
eldercare, with UM’s expertise implementing evidence-based pain management and
prevention and treatment of OUD—specifically screening, opioid tapers, and provision of
medication assisted treatment (MAT). In alignment with AHRQ’s mission, we aspire to
implement, study, and disseminate methods by which to provide safer and more equitable
pain management care to older adults.

Public health relevance
Project Narrative. Public Health Impact. A large percentage of older adults receive most of their health care through visits to their PC provider. Improving analgesia while decreasing morbidity and mortality related to opioid use in older adults requires adapting and testing approaches to improving pain management in these PC practices, with special attention to the social and physical risks specific to this population. The Managing Pain Safely in Older Adults project team is uniquely qualified to lead such an effort.